Pre-Clinical Assessment of a Minimally Invasive Meniscus Implant to Delay Arthritis

Abstract
Meniscus tears are among the most common orthopedic injuries, with about 1 million occurring in
the United States each year and growing at a rate of 5% annually. Shortcomings associated with
the current standard of care leaves a clinical need for a new treatment option. The meniscal tissue
can only be repaired in limited cases due to its healing capacity, so the most common treatment
for meniscal tears is removal of the damaged tissue, or a meniscectomy. The contact stress in
the joint increases proportionally with the amount of meniscus tissue removed due to the decrease
in contact area, and this increase in contact stress frequently leads to articular cartilage damage
and the development of osteoarthritis (OA). Once a patient damages their articular cartilage,
which causes chronic pain and impacts knee function, the patient has few choices. Most patients
must undergo a total knee replacement to relieve their symptoms, which is a very invasive surgery
with permanently debilitating consequences. Since most meniscectomies are performed on
patients under the age of 55, the patient is often too young to be considered for a total knee
replacement and is need of an alternative option. OrthoPreserve, a small business of clinicians
and engineers, is developing an artificial meniscus implant to fill the significant treatment gap for
patients during the time between a meniscus injury and a knee replacement. There are currently
no meniscus implants available on the consumer market in the United States, so this device has
the potential to disrupt the orthopedic market and provide a breakthrough treatment option.
Previous studies on the implant have demonstrated its ability to restore the natural contact
pressure distributions within the knee joint, and significant mechanical testing on the implant’s
composite material has shown that the material is strong and durable enough to withstand the
forces that the meniscus experiences in the knee. In Phase I, OrthoPreserve will demonstrate the
feasibility of this meniscus implant to become a viable product in the treatment of meniscus
injuries and delay of arthritis through three specific aims. Aim 1 will assess the safety and efficacy
of the implant in an animal model. Aim 2 will refine a minimally invasive implantation method for
the implant within human cadaver knees and provide insight into potential attachment redesigns.
Aim 3 will show that size variations can allow the implant to restore function while also remaining
securely fixed in the joint after cyclic use in various knee sizes. A significant market opportunity
exists for OrthoPreserve’s meniscus implant, and this technology can enhance quality of life for
millions of patients and reduce overall healthcare burden in meniscus injury and OA treatment.

Public health relevance
Narrative Meniscus tears are one of the most common orthopedic injuries in the United States, and the treatment options for this painful and impairing condition are extremely limited. The standard of care is to cut out the damaged tissue, which ultimately leads to the progression of knee arthritis and the need for a costly and burdensome procedure - a total knee replacement. OrthoPreserve is developing an artificial meniscus replacement for meniscus injury patients that can restore knee function, protect the joint to delay arthritis, and remains strong enough to prevent secondary failure.